Continued Development and Maintenance of the UltraScan Software

Project Summary/Abstract
We propose to continue development and support for the free and open source UltraScan-III (US3) software
suite and develop new code and methods to address challenging biomedical research questions that can be
solved with the latest instruments available for analytical ultracentrifugation and at beamlines for small-angle
X-ray and neutron scattering experiments (SAXS/SANS) experiments. UltraScan is a comprehensive toolkit for
the analysis of data from hydrodynamic experiments and simulations. Such experiments include analytical
ultracentrifugation and solution bio-SAXS/SANS, as well as bead modeling simulations. Support for this project
will assure continued availability of a mature multi-platform analysis suite with important and unique capabilities
not found in any other software packages. Chief among them are tight integration of supercomputing
capabilities, LIMS support for collaboration, and specialized analysis routines. US3 enjoys world-wide use in
the AUC and SAXS/SANS communities, and offers the most robust optimization and simulation algorithms
available, resulting in unmatched detail. UltraScan provides the highest throughput, a flexible, modern GUI,
and a comprehensive list of analysis routines. Proposed new developments include improved automation for
data acquisition, analysis, and reporting workflows, and new tools to support electronic signatures and audit
trails to satisfy 21 CFR Part 11 requirements. These developments will increase the reliability and rigor of
UltraScan analysis, and improve safety for patients by assuring reproducibility of therapeutic drug
characterization by AUC.

Public health relevance
Project Narrative The proposed work will further develop and continue to maintain the UltraScan software suite, which contributes to the analysis of biophysical solution data with unmatched resolution and efficiency. Among the proposed developments are codes to provide comprehensive and automated reporting to support GMP operation of analytical ultracentrifugation experiments performed with the Beckman-Coulter Optima AUCTM instrument, to offer electronic signatures and audit trails for GMP operation, and automated tools for structure determination. These efforts are highly relevant for many current NIH and NSF investigations, support the development of therapeutics against any disease studied on the molecular level, contribute important tools for studies into the mechanisms of aging, cancer, HIV, and neurodegenerative diseases, improve patient safety through rigorous characterization of drugs, and inform investigations into their interactions with drug targets.